Aging Well with HIV through Alcohol Research and Risk Reduction and Education (AWAR3E) Center

AWAR3E Overall
People with HIV (PWH) experience more “inflammaging” characterized by chronic inflammation, immune
dysfunction, and debilitating geriatric syndromes than people without HIV (PWoH). Inflammaging has not been
well characterized among people with HIV because no single cohort can adequately address this question.
Thus, before we can effectively intervene on this health issue, we need to characterize inflammaging among
people with HIV to identify appropriate biomarkers, outcomes, and treatments. We bring together four well
characterized, complimentary HIV cohorts to study this question in the Aging Well with HIV through Alcohol
Research and Risk Reduction and Education (AWAR3E) Center. We propose that inflammaging in people with
HIV is reflected in novel biomarkers of inflammaging (methylation age, HIV-1 viral reservoirs, and Conserved
Transcriptional Response to Adversity [CTRA]; Project 1: Biomarkers) and is associated with debilitating
geriatric syndromes (falls/fractures, delirium/dementia, and physiologic frailty; Project 2: Geriatric Syndromes).
We also explore two potential treatments to counteract inflammaging, long-acting ART (LAARs, e.g. injectable
cabotegravir-rilpivirine) and glucagon-like peptide-1 receptor agonists (GLP-1RAs, e.g., semaglutide; Project 3:
Treatments). We hypothesize that people with HIV, those with unhealthy alcohol use, and those
socioeconomically disadvantaged are less likely to receive these treatments than those without these factors,
but are more likely to benefit from each. We evaluate their safety and effectiveness overall and for people with
unhealthy alcohol use and socioeconomic disadvantage using causal modeling. Finally, the AWAR3E Center
will provide guidance and coordination of this work with an Administration and Data Core, Program Advisory
Group, Steering Committee, Engagement and Dissemination Core, and Pilot Program focused on training the
next generation of investigators and community representatives in alcohol-HIV/AIDS research to promote
health. Insights gained, training provided, and strategic engagement and dissemination through the
AWAR3E Center will facilitate future alcohol interventions tailored to people with HIV to mitigate
inflammaging associated health outcomes.

Public health relevance
Overall Narrative We propose the Aging Well with HIV through Alcohol Research and health Equity promotion (AWARE) Center to characterize drivers of premature aging among Black men and women, gay and bisexual men, and transgender women with HIV to inform future interventions, clinical care and policy. The center will coordinate and promote research on the associations of unhealthy alcohol use with biomarkers of premature aging, with aging associated health syndromes and with the effectiveness and safety of medications that may help counteract premature aging in these groups.